Evaluating seasonality of influenza in the tropics: Case study in Vietnam

PROJECT SUMMARY
Influenza is a persistent viral disease worldwide, with high case counts leading to deaths and losses in
productivity yearly. In temperate regions of the world, such as the United States, influenza appears in annual
wintertime cycles, with the influences of changing seasons creating predictable patterns of incidence, despite
the fact that different subtypes and strains of the virus predominate during each season. In tropical regions,
distinct seasonal patterns are not well established for influenza, suggesting that annual or climatic forces may
not dictate transmission in these areas. The tropics include many resource-limited areas of the world where
respiratory disease research is underfunded and influenza vaccination is not prioritized. Transmission patterns
of influenza can be described through the use of mathematical models, which incorporate known biological
mechanisms, such as infectivity, recovery, and duration of immunity following infection, in order to describe the
dynamics, or population-level behaviors, of the virus. Models can incorporate cyclic patterns of influenza
dynamics, which can include both seasonal cycles aligning with a calendar year as well as nonannual periodic
cycles; models can also incorporate irregular epidemics, though this is more challenging to model and less
commonly seen in current literature. Irregular epidemics can be viewed as “regime switches,” which describes
transitions between endemic time periods with consistently low incidence and epidemic time periods with short
periods of elevated incidence. This study aims to investigate potentially cyclic or acyclic dynamics of influenza
in the tropics, using Vietnam as a case study. The first aim seeks to define patterns describing cyclic or acyclic
dynamics and then use a mathematical model to show under what conditions acyclic dynamics can exist.
Influenza characteristics that could allow acyclic dynamics potentially include duration of immunity following
infection, cross-immunity, and population structure. The second aim seeks to use the developed model as well
as influenza data from Vietnam to determine whether influenza dynamics follow cyclic or acyclic patterns.
Comparing these results to identical analyses using data from temperate regions influenza data will allow us to
compare the strength of annual cycles between tropical and temperate regions. The third aim seeks to identify
characteristics of influenza virus, population patterns, or external factors that may be able to explain the cyclic
or acyclic patterns observed in influenza dynamics in Vietnam. This will show what characteristics of influenza
or external factors provide the strongest predictions of future influenza incidence in Vietnam. Uses of the study
results include better informed and appropriately-timed vaccination strategies for influenza in Vietnam. The
main points of novelty in this study lie in the explicit testing for cyclic or acyclic patterns in the tropics, which is
less commonly investigated, and a mechanistic modeling approach to identify the potential causes of non-
annual behavior of influenza transmission in the tropics.

Public health relevance
PROJECT NARRATIVE Influenza persists globally, causing nearly one billion cases and hundreds of thousands of deaths annually. While temperate regions of the world experience regular seasonal patterns of influenza with high predictability, tropical regions, many of which are resource-scarce, do not have well-established evidence of regular cycles of influenza epidemics. The proposed research seeks to use mathematical models to determine whether tropical regions experience regular cycles of influenza epidemics or irregular epidemics, using surveillance data from Vietnam as a case study, which can allow tropical nations to understand the predictability, or lack thereof, of influenza.